Viral determinants of Bacterial Vaginosis and HIV acquisition risk in the female genital tract

The female genital tract (FGT) is colonized by millions of microbial taxa that have far reaching effects on
reproductive health. Resident bacteria in the FGT affect mucosal immune responses, alter the risk of STI
acquisition, and predict maternal health and birth outcomes, with lactobacilli typically associated with reduced
overall bacterial diversity, inflammation, and risk of STI acquisition. Conversely, communities with little
representation of Lactobacillus and an increased abundance of diverse anaerobes are characterized as
Bacterial Vaginonsis (BV) and are associated with elevated levels of inflammatory cytokines, heightened risk of
STI acquisition and adverse birth outcomes, vaginal discharge, and other sequelae. However, the mechanisms
underlying transitions to BV and its high recurrence rates after antibiotic treatment (~50%) remain unknown.
The vaginal virome remains largely uncharacterized outside of a few families of DNA viruses associated with
adverse conditions (Herpesviridae, Papillomaviridae), with the RNA virome even less studied. Bacteriophages,
including integrated prophages, are powerful mediators of bacterial community structure and dynamics across
environments, though we know little of bacterial-phage interactions in the the FGT. This study proposes that
the vaginal virome is one of the factors influencing transitions to BV, either by eliciting mucosal immune
responses directly, or via bacterial-phage dynamics, including prophage induction via abiotic stressors. This
proposal will utilize samples already collected from the Evidence for Contraceptive Options and HIV Outcomes
(ECHO) Trial to longitudinally characterize (via shotgun metagenomics) interactions between viral and bacterial
taxa in participants who do not experience BV (20), participants who experience and clear incident BV (20),
and participants who experience persistent BV (20) (Aim 1). We will use strain-resolved analyses to identify
alterations in prophage abundance, as well as non-integrated viruses, and we will integrate these data with
measurements of 27 cytokines measured previously. In Aim 2, we will characterize the vaginal viral and
bacterial metagenomes in our full cohort of participants that seroconverted (28) during our substudy and
compare those with the same number of matched controls, identifying alterations in the abundance and
functionality of bacterial and viral taxa between groups. In Aim 3, we will follow up the results from our previous
work demonstrating that a copper intrauterine device (Cu-IUD) shifted vaginal bacteria toward BV states. We
will sequence the bacterial and viral metagenomes across the full subset of women randomized to the Cu-IUD
(60) prior to initiation and after six months of use to identify if Cu2+ released from the IUD induced prophages
into lytic replication using strain resolved analyses similar to Aim 1, with special attention to lactobacilli
prophages. We will assess the results from our metagenomic analyses in vitro via culture experiments using
Cu2+ for prophage induction. Together, these aims will provide a characterization of the vaginal virome and its
contributions to BV and associated sequelae, including HIV acquisition.

Public health relevance
PROJECT NARRATIVE Bacterial Vaginosis (BV) affects millions of women annually, leading to increased vaginal inflammation, elevated susceptibility to STIs, adverse birth outcomes, and a reduction in quality of life. However, our understanding of the factors influencing transitions to BV, as well as the mechanisms underlying its persistence and recurrence, are incomplete. This project utilizes integrative metagenomics to characterize the interplay between vaginal viral and bacterial communities, how they are shaped by contraceptive use, and how these dynamics may alter HIV acquisition risk.